REGULATION OF NEUROTRANSMITTER RECEPTORS BY CELL DIFFERENTIATION

The understanding of the molecular mechanisms of the differentiation of neurons during development is of fundamental importance in neuroscience. We have used two neuronal hybridomas, NCB-20, and NG108-15 cells, to study the receptor regulation induced by two differentiation promoters, dibutyryl cAMP (Bt2 cAMP) and butyrate. Exposure of cells to Bt2cAMP caused a time and dose dependent decrease in the binding to muscarinic acetylcholine, adrenergic alpha2 and opioid delta receptors. The loss of muscarinic cholinergic receptor site assessed by using 3H-QNB as the binding ligand was about 40% of the control; this decrease was associated with an attenuation of the carbachol-induced phosphoinositide hydrolysis. The maximal decreases of adrenergic alpha 2 and opioid delta receptor binding were about 80% when 3H-clonidine and 3H-D-Ala-D-Leu- enkephalin (DADLE) were used as their respective ligands. In contrast, butyrate induced a time and dose dependent increase in the opioid receptor binding sites. The maximal increase was about 300% of the control when 1 mM of butyrate was added to the culture for 72 hrs. The up-regulation of opioid receptor resulted in an increased potency of DADLE in inhibiting adenylate cyclase activity. Similar butyrate treatment up-regulated muscarinic receptors by 100% and increased carbachol-induced phosphoinositide by about 200%. Long term butyrate treatment on NG 108-15 cells did not change muscarinic and opioid receptor binding but induced a 100% increase of the density of alpha 2- adrenergic receptors. Butyrate treatment induced cell morphological changes which were distinct from those induced by Bt2cAMP. These results suggest that these two differentiation agents can either up-regulate or down-regulate neurotransmitter receptor proteins. Moreover, up-regulation of neurotransmitter receptors induced by butyrate may involve concerted interactions of genetic factors derived from both parents of these two neurohybrids.